Resubmission - Test of a Training Program That Uses Virtual-Reality Technology to Improve Children's Pedestrian Behaviors: A Randomized Controlled Trial

Abstract Motor vehicle pedestrian injury is a critical issue for school children.1-4 Each year in the US, over 4900 pedestrians are killed and another 207,000 are injured, and about 25% of these pedestrian events involve school-age children. This research focuses on 7-8 year olds, who constitute a high-risk group for pedestrian injury.1-4 At these ages children regularly cross streets without supervision5,6 and they struggle both with selecting where to cross7,8 and determining how to cross.9,10 Research has shown, however, that they are capable of benefiting from effective behavioral training in pedestrian behavior. The proposed research addresses the issue of crossing skills deficits and will: (1) implement a randomized controlled trial (RCT) to test two alternative training programs to teach 7-8 year-olds where and how to cross streets safely; and (2) conduct an economic analysis to reveal cost:benefit indices for both. Meta-analyses of pedestrian training programs31-33 reveal that behavioral training in a traffic environment most reliably produces some degree of improvement in crossing skills.18,26,33,35,36 Thus, ?street-side training? is often described as the gold standard. Implementation, however, poses many practical problems related to implementation. Our laboratory has addressed this issue by developing a training system that uses a virtual pedestrian environment and extends past VR systems by having children fully cross the street and offering the unique capability of teaching both where and how to cross, with skills in each domain measured separately so exactly what is learned and what component crossing behaviors improved can be precisely determined for each individual child. Children (7-8 years) will be randomized to one of three groups (balanced for sex): street-side training, virtual-reality training, and a no-intervention control, with the same pre- and post- measures taken across groups. Primary analyses will test for changes in indices of where and how to cross, as well as attention to traffic when crossing. An economic analysis of the two programs will reveal their relative cost effectiveness. These results will provide essential knowledge to inform future decisions about ?best practices? in child pedestrian injury prevention through behavioral training.

Public health relevance
Narrative Injury is the leading cause of death for American youth, and motor vehicle pedestrian injury is a critical issue for elementary-school children. This research proposes a randomized controlled trial to evaluate two pedestrian training programs to improve children’s abilities to determine where to cross and how to cross streets safely, with an economic (cost:benefit) analysis of the two programs also being conducted. The results are expected to guide future decisions about ‘best practices’ to reduce child pedestrian injury through behavioral training.